Risk stratified survivorship care pathways for early-onset colorectal cancer

Abstract: Over the past two decades, the incidence of colorectal cancer among adults < 50 years of age (i.e.,
early-onset CRC) has been alarmingly and steadily increasing. Despite these increases, survivorship care has
evolved slowly and remains poorly informed and of suboptimal quality. Patients with early-onset CRC are
particularly vulnerable to suboptimal care, given that the disease is more often diagnosed in racial and ethnic
minorities and at a stage in life when financial instability and being medically underinsured or uninsured are
more common. Thus, there is a critical need to design a model of survivorship care that aligns: 1) the intensity
of surveillance with actual risk of recurrence; and 2) the provision of care services with need. Stratified
survivorship care pathways provide an opportunity to deliver patient-centered, high-quality care that is
appropriately tailored to individual needs. However, these pathways currently do not exist for patients with
early-onset CRC, which is in part due to the lack of population-based estimates of recurrence that can guide
surveillance approaches and the dearth of knowledge regarding these patients’ unique survivorship care
burdens and needs. In this proposal, we will partner with three SEER registries in Georgia, Kentucky, and Los
Angeles County to apply a new methodology to identify patterns of recurrence among patients with stage I-III
early-onset CRC, generate population-level estimates of risk of recurrence, and examine clinical and
sociodemographic factors associated with recurrence risk (Aim 1). We will then survey a contemporary and
diverse SEER-based cohort of patients diagnosed with early-onset CRC to assess patients’ receipt of
surveillance and self-reported survivorship care needs across multiple domains (e.g., physical symptoms,
financial issues, family planning) (Aim 2). Finally, informed by findings from Aims 1 and 2, we will develop a
stratified survivorship care framework and care pathways with a multi-disciplinary Advisory Panel (Aim 3). We
will engage patients, caregivers, and clinician stakeholders in a consensus panel using the RAND/UCLA
Appropriateness Method to refine and finalize the stratified survivorship care framework and care pathways.
We will then assess the acceptability, appropriateness, and feasibility among the stakeholders. This study will
yield much-needed population-based estimates of recurrence risk, surveillance intensity, and
survivorship care needs and generate stratified survivorship care pathways for this rapidly growing
population of cancer survivors. The findings have the potential to meaningfully improve the quality of
survivorship care for patients with early-onset CRC and advance the science of stratified survivorship care
delivery for other cancers more broadly.

Public health relevance
PROJECT NARRATIVE This study will utilize large and diverse registry-based samples of patients with early-onset colorectal cancer to estimate the risk of recurrence associated with clinical and sociodemographic data and characterize surveillance intensity and survivorship care needs across multiple domains using patient surveys. Using these population-based estimates of recurrence risk and patient care needs, we will then engage with clinician, patient, and caregiver stakeholders to develop and evaluate a stratified survivorship care framework and care pathways to improve care for this understudied and growing population of patients.